5 ALPHA REDUCTASE 2 DEFICIENCY--STUDIES OF DIHYDROTESTOSTERONE IN FEMALES

The specific aim of the major part of this study is to characterize the role of the hormone DHT in female physiology and to test the hypothesis that DHT plays a role in normal sexual hair development, the menstrual cycle, and in the development of hirsutism, acne and polycystic ovarian disease.